Investigating the Role of CDC42 and RAC1 in Germline Cyst Breakdown and Primordial Follicle Formation

PROJECT SUMMARY
In the United States today, women are delaying having children. This is a critical issue because as a woman
ages, her reproductive capability decreases as the ovarian reserve diminishes. Additionally, approximately 1%
of women in the United States are diagnosed with primary ovarian insufficiency, by which the quantity and/or
quality of the ovarian reserve is reduced. The ovarian reserve is formed between weeks 9 to 13 in gestation in
humans and at the time of birth in mice; once it’s depleted, ovulation and conception can no longer occur. The
ovarian reserve is comprised of primordial follicles, a singular oocyte surrounded by supporting pre-granulosa
cells. The establishment of ovarian reserve is the result of germline cyst breakdown. During this process,
connections between sister oocytes breakdown and singular oocyte primordial follicles are formed. The long-
term goal of the Jorgensen lab is to understand cell-cell interactions and signals that direct germline cyst
breakdown and primordial follicle formation. The objective of this proposal is to determine the role Rho
GTPases, CDC42 and RAC1, play in modulating cell-to-cell connections during the transition from oocyte-
oocyte to oocyte-pre-granulosa cells when new primordial follicles form. Aim 1 will test the idea that CDC42
and RAC1 are present in the ovary during germline cyst breakdown and primordial follicle formation and
interact with CDH1 in the ovary. It has been suggested that CDC42, RAC1, and CDH1 are essential for proper
primordial follicle formation but the connection between these three proteins has yet to be explored.
Preliminary data suggest that CDC42 and CDH1 are both oocyte-specific throughout the processes of germline
cyst breakdown and primordial follicle formation. Aim 2 will test the hypothesis that CDC42 and RAC1 are
essential for proper primordial follicle formation. Using conditional knockout mice, I will characterize the
phenotype and functionality of the ovary absent of CDC42 and/or RAC1 prior to germline cyst breakdown.
Additionally, I will employ live imaging of germline cyst breakdown and primordial follicle formation in wild-type
and conditional knockout animals to understand how the loss of CDC42 and/or RAC1 affects germline cyst
breakdown and primordial follicle formation in real-time. In total, these studies will uncover the role of CDC42
and RAC1 in germline cyst breakdown and primordial follicle formation which will provide insight into early
ovarian development and ultimately fertility.

Public health relevance
PROJECT NARRATIVE Germline cyst breakdown and primordial follicle formation are crucial to the formation of a healthy ovarian reserve, and thus a woman’s fertility. This proposal aims to understand how two Rho GTPases, CDC42 and RAC1, influence the cytoskeleton of developing oocytes to form healthy and long-lasting primordial follicles. Upon completion of this project, we will have a better understanding of how germline cyst breakdown and primordial follicle formation occur, helping to understand an important aspect of women’s reproductive health.